Renal endothelium and the development of chronic kidney disease in sickle cell disorders

PROJECT SUMMARY/ABSTRACT
Chronic kidney disease (CKD), widespread among individuals with sickle cell disease (SCD), is a significant
contributor to morbidity and early mortality. The progressive deterioration of renal health in SCD is associated
with chronic intravascular hemolysis. However, the mechanistic approach to interpreting the hemolysis-driven
pathogenesis of CKD in SCD is limited and therefore targeted therapies based on mechanistic models are
lacking. Progressive loss of renal function, represented by increased albuminuria and reduced glomerular
filtration rate (GFR), is associated with microvascular congestion in humans and mice with SCD. We postulated
that circulating cell-free heme, a product of hemolysis, may instigate persistent endothelial damage that ensues
CKD development. Endothelial protein C receptor (EPCR) maintains endothelial barrier integrity. We discovered
an age-dependent as well as heme-induced loss of EPCR from renal microvascular endothelium in SCD (SS)
mice. Concomitantly, the cleaved soluble form of EPCR (sEPCR) was elevated in the plasma associated with
albuminuria. Using super-resolution ultrasound imaging, we found that younger SS mice challenged with the
repetitive infusion of minimal doses of heme and the older SS mice without heme challenge incur substantial
renal microvascular rarefaction. Heme induces endothelial P-selectin that promotes vascular congestion. Our
pilot data show that reduced EPCR expression is associated with increased P-selectin on renal microvascular
endothelium in the SS mice. Proteinase 3 (PR3), expressed on neutrophils, can degrade EPCR. In our repeated
heme-challenged younger SS mice compared to vehicle-injected mice, we noticed increased expression of PR3
in plasma as well as in accumulated neutrophils from the kidneys. Moreover, we found that heme induces
acetylation of histone 4 Lys 16 residues (H4K16ac) which are known to promote the biosynthesis of PR3. Based
on these preliminary data, we hypothesize that heme-induced P-selectin and PR3 concurrently result in the loss
of EPCR leading to endothelial disintegration, microvascular congestion, and CKD development in SCD. We will
test this hypothesis with three specific aims that integrate experiments with human renal endothelial cells and
neutrophils in vitro, murine models, and clinical samples from multiple cohorts of SCD patients.
Aim 1 will determine that repeated low-dose heme insults promote renal endothelial P-selectin that suppresses
EPCR leading to vascular damage and development of CKD in mice with SCD. Aim 2 will test whether heme-
activated PR3 facilitates EPCR cleavage and expedite CKD in SCD. Aim 3 will determine whether sEPCR and
specific genetic variants of EPCR can indicate the risk of CKD in SCD patients.

Public health relevance
Progressive chronic kidney disease (CKD), associated with intravascular hemolysis, is a steady predictor of morbidity and early mortality in sickle cell disease (SCD). This project seeks to determine that circulating heme, the hemolytic byproduct, downregulates endothelial protein C receptor (EPCR) through induction of endothelial P-selectin and neutrophilic proteinase 3 (PR3) resulting in renal microvascular endothelial damage and CKD development. The project will assess whether specific genetic variants and soluble form of EPCR are associated with the risk of CKD, and identify specific intermediate therapeutic targets to impede CKD pathogenesis in SCD.